THE PROPERTIES OF BILAYERS CONTAINING GLYCOSPHINGOLIPIDS

The research outlined in this proposal centers on the investigation of the biologically relevant system properties of lipid bilayers formed from well characterized phospholipids and cholesterol which contain variable amounts of glycosphin-golipids of the types found in mammalian cell plasma membranes. Emphasis is placed on the examination of bilayers in the form of single lamellar vesicles which have glycosphingolipid incorporated only on the outer surface; a system which is the analog of the plasma membrane bilayer. Multilamellar liposomes as well as large and small unilamellar vesicles will be utilized in this work which will depend upon a variety of physical techniques including fluorescent probes, NMR spectroscopy (1H, 2H, 13C and 31P) scanning calorimetry, partial molal volume measurement, autocorrelation light scattering as well as hydrodynamic methods to characterize vesicle dispersions.